2025 Pediatric Dermatology Research Alliance (PeDRA) Annual Conference

PROJECT SUMMARY

Pediatric skin diseases are highly prevalent and impart a devastating burden on children and
their families. Yet, the specialty of pediatric dermatology is understaffed, the availability of FDA-
approved treatments is inadequate, and the pace of research and guidelines development in
the field is too slow. The Pediatric Dermatology Research Alliance (PeDRA) was founded in
2012 to address these crucial yet unmet needs. PeDRA's primary mission is to create, inspire,
and sustain research to prevent, treat, and cure childhood skin disease. The long-term goal of
PeDRA is to leverage such research to improve the health outcomes of children with skin
disorders. Annual conferences have been integral to the success of PeDRA, providing a forum
for educating investigators, identifying and prioritizing research needs and opportunities, and
developing and initiating innovative projects. A combination of didactic lectures and panels,
expert-led small group discussions, poster sessions, and unique training opportunities are the
foundation of every PeDRA Annual Conference. This proposal is for the 13th PeDRA Annual
Conference, set to take place in October of 2025 with the following aims: 1) Provide education,
presentation, and networking opportunities while advancing consensus-building skills related to
collaborative pediatric dermatology research and shared decision making for the care of
children with skin diseases; 2) Advance existing research projects and develop new research
priorities and initiatives in disease areas and high-priority topics spanning the field of pediatric
dermatology; and 3) Provide a forum for the dissemination of final and ongoing research results
to an audience that includes patient stakeholders, industry representatives, and researchers
from multiple fields including potential NIH collaborators. The expected outcomes of this
conference are a more developed set of research skills for current and future physician-
scientists, enhanced productivity, strengthened multi-stakeholder networks, and the conduct of
high-quality research. These activities will accelerate the pace of pediatric dermatology
research, allowing clinicians to better understand, prevent and treat skin disease in children,
and give patients and families options to manage diseases and make informed treatment
decisions in the future.

Public health relevance
PROJECT NARRATIVE Established in 2012, the Pediatric Dermatology Research Alliance (PeDRA) is a nonprofit research organization driven by the mission to create, inspire, and sustain research to prevent, treat, and cure childhood skin disease, and the PeDRA Annual Conference has been integral to the organization’s growth and success since the first conference in 2013. In 2025, its 13th annual conference will continue PeDRA’s work to educate and empower physician-scientists, trainees, and other stakeholders through an agenda that disseminates results, supports the identification of high-priority questions, and facilitates science with a focus on building consensus for children with skin diseases and conditions. The conference will accelerate the pace of pediatric dermatology research in pursuit of PeDRA’s vision of changing lives and healing children with skin disease through collaboration and discovery.